Summer Undergraduate Research Support - Ms. Anastasiia Fisiuk

Field 7-Project Summary
PLACEHOLDER
PA-20-272 says section 7 should also be included if there are changes by the proposed
supplement activities. Although there are no changes, a document is required per
Grants.gov instructions.

Public health relevance
Field 8-Project Narrative PLACEHOLDER PA-20-272 says section 8 should also be included if there are changes by the proposed supplement activities. Although there are no changes, a document is required per Grants.gov instructions.